Center for Health Equity in Cognitive Aging - Joining Population Science and Health Promotion (CHECA)

Project Summary/Abstract We propose an Alzheimer's-related Resource Center for Minority Aging
Research (AD/ADRD RCMAR) at University of Illinois Chicago (UIC) called the “Center for Health Equity in
Cognitive Aging” (CHECA). CHECA will support the development of new equity-focused ADRD research at
UIC by building behavioral and social research infrastructure (Aim 1), diversifying the AD/ADRD research
workforce through mentorship and training for early-career Scientists (Aim 2), and supporting pilot research
(Aim 3). The research supported by CHECA will address 3 complementary themes: (1) advancing our
understanding of environmental, sociocultural, and behavioral contributors of ADRD inequities; (2) developing
and testing health-promoting resources (e.g., physical activity or stress-coping interventions; support from
families, communities, or healthcare systems; information and technologies) appropriate for the needs of adults
aging with or at risk for AD/ADRD and their care partners; and (3) cross-fertilizing population science and
health promotion approaches to innovate our understanding of structural, social, and behavioral drivers of
ADRD inequities and to maximize our intervention effects. In all of its work, CHECA is committed to centering
diverse perspectives, intra-group variations, and an intersectionality lens across overlapping identities (e.g.,
race, ethnicity, gender and sexual identity, class, disability). The Leadership and Administrative Core (LAC) will
provide scientific and intellectual leadership, strategic direction, and administrative oversight to produce
synergy across CHECA cores. The Research Education Component (REC) will provide a mentoring program
for RCMAR Scientists to support their long-term careers, will implement the pilot funding program (solicitation,
review, and selection of pilot studies for funding), and will empower CHECA Scientists with tools and training
relevant to the CHECA themes. The Analysis Core (AnC) will support Scientists' pilot projects through
statistical/methodological consultation and mentoring while also enriching CHECA's methodological
infrastructure accessible to all CHECA-affiliated scholars and faculty members. The Community Liaison
Recruitment Core (CLRC) will provide CHECA Scientists and their mentors with training opportunities and
resources for conducting community-engaged research, and will facilitate bi-directional collaborations between
CHECA and community partners. Establishing CHECA will enable an increasingly diverse cadre of scholars at
UIC to build on our strong track record of research with older underrepresented minority populations locally
and nationally. As a federally designated Minority-Service Institution, Asian American and Native American
Pacific Islander-Serving Institution, and Hispanic-Serving Institution, UIC provides a fertile ground for a new
AD/ADRD RCMAR that focuses on joining population science and health promotion research to better
understand and address ADRD-related health inequities.

Public health relevance
Project Narrative This project will establish research and mentoring infrastructure to create and sustain a diverse, equitable, inclusive, and accessible aging research community in social and behavioral sciences to advance research on Alzheimer's disease and related dementias. The team-based research community will support early-career faculty members from diverse background to conduct pilot studies to enhance the well-being of adults aging with or at risk for Alzheimer's Disease Related Dementia and those who care for them.